CORE--MOUSE PATHOLOGY

This purpose of this Core is to provide for centralized pathology review of all tissues obtained from the murine models developed in the individual projects. Through these activities, this Core will play an essential role in defining the spectrum of tumors that develop in the various mouse strains, thus facilitating their accurate classification. This activity will allow meaningful comparisons to be made between the morphology and defined genetic, biochemical, physiologic, and gene expression data obtained on these tumors. Moreover, this centralized review will help to define the relationship of the murine tumors to the relevant human disease under study. This Core laboratory will perform necropsies on all sacrificed mice, and will process tissue, prepare microscopic slides, and evaluate the microscopic morphology of the isolated organs, body fluids, and identified neoplasms/ In addition, immunohistochemistry studies will be performed on all tumors to define tumor lineage and extent of differentiation. Dr. Jerold Rehg, who is a diplomat of both the American College of Veterinary Pathologist and the American College of Laboratory Animal Medicine, will lead this Core. He has extensive experience in the morphologic analysis of mice and will provide an outstanding level of expertise. The efforts of this laboratory will be further supported by the participation of Dr. Downing, Program Leader, who bring 15 years of experience in human pediatric tumor pathology. His participation will facilitate the comparison of the murine tumors to comparable tumors that arise within the pediatric population. In addition to these routine studies, this laboratory will provide expertise in laser-activated tissue microdissection, which will facilitate the ability to define differences in gene expression and mutation analysis between heterogeneous areas within a tumor.